Regulation of cortical circuit formation by subcellular compartmentalization of mRNA translation

Project Summary/Abstract
Cerebral cortex and other projection neurons extend axonal projections 103-105 times longer than their cell body
diameters with exquisite precision. Growth cones (GCs) are specialized subcellular compartments that interpret axon
guidance and target-derived signals, and carry out subtype-specific programs to ensure appropriate circuit and synapse
formation. Because GCs extend so far from cell bodies that it takes hours to days to send molecules to them via axonal
transport, GCs must be “semi-autonomous”. Local translation has been proposed as a mechanism for local control of
growth cone function, but the types and diversity of locally translated mRNAs in vivo is largely unknown. More broadly,
translational regulation in neurons is likely a crucial mechanism for properly establishing and maintaining long-range
circuitry. Multiple neurodevelopmental (ex: Fragile X-Syndrome), and neurodegenerative (ex: ALS/FTD) diseases are
caused by mutations in RNA binding proteins that both directly and indirectly disrupt several aspects of RNA processing,
and culminate in altered translational output. My project addresses how translational regulation contributes to the
development of subtype identity and cortical circuit formation by employing our newly-developed, low-input ribosome
profiling approach to: 1) compare translational outputs and identify mRNAs in the somata that are differentially translated
between multiple specific cortical projection neuron subtypes; 2) analyze the full landscape of local translation in callosal
projection neuron (CPN) GCs to identify candidate regulators that are specifically locally translated in GCs; 3)
functionally investigate novel, select locally GC-translated candidates in callosal projection neuron circuit formation.
This project undertakes a relatively comprehensive, in vivo investigation of both subtype differences in translation, and
local translation and its mechanisms in GCs. The data generated and concepts explored will provide a deep and rigorous
foundation for understanding translational regulatory diversity and distinctions between neural subtypes, and the
categories of mRNAs locally translated in GCs during circuit development. Beyond rigorously investigating the unique
biology at the intersection of circuit formation, RNA trafficking, and translational regulation in distal neuronal subcellular
compartments, it also has substantial

Public health relevance
Project Narrative Translational regulation has been shown to be dysfunctional in neurodevelopmental and neurodegenerative diseases, and this project employs novel, newly-developed low-input ribosome profiling approaches to directly measure subcellularly-localized translational output in mouse cortical projection neuron subtypes, both in their cell bodies and in their growth cones, enabling comprehensive investigation of how translational regulation contributes to the formation and potential degeneration of long-range cortical circuits needed for control of complex behavior. Neurons extend specialized structures called growth cones, which traverse very long distances through the nervous system to establish the connections that enable complex behavior. Because growth cones both extend far from their parent cell bodies– often many thousands of cell body diameters– and recent data reveal that they carry intrinsic RNA programs that enable them to distinguish proper from improper connections and maintain these, growth cones locally translate important proteins to facilitate “semi- autonomous” function; this project uniquely investigates the mechanisms underlying these important issues.